A Decision Support Tool for the Discontinuation of Disease Modifying Therapies in Multiple Sclerosis

Project summary
The treatment of multiple sclerosis (MS) has been transformed with the introduction of disease-modifying
therapies (DMTs), but these medications DMTs have known risks and are a significant financial burden for
many people with MS and for the healthcare system as a whole. Nationally, prescription drugs account for 10-
15% of total healthcare spending, but, for people with MS, prescription drugs account for more than two-thirds
of their total healthcare expenditures. The benefits of DMTs are clear early in the disease course, where they
have been shown to prevent relapses and the accumulation of lesions in the central nervous system. Later in
the disease course, the combination of immunosenscence and a shift from widespread neuroinflammation to
neurodegeneration results in diminished biological benefits of DMTs and a shift in the risk/benefit ratio in
people with MS. The most common risks associated with DMTs are infections, which have been reported to be
as high as 19.7 per 1000 person-years. Studies have also shown that infectious complications tend to increase
with both age and increased years of DMT exposure. For these biological, financial, and risk reasons
discontinuation of DMT in certain individuals should be considered. There is a growing body of observational
research supporting the notion that there is a safe time to discontinue DMTs with a low risk of recurrent
disease activity. These studies all suggest that older patients who have been on a DMT for several years
without active disease (no relapses, no new MRI lesions) have a low likelihood of recurrent disease activity
after discontinuing DMT. Despite the growing evidence to support DMT discontinuation there is a lack of
consensus from neurological societies and there is no standardized approach to this clinical decision. This
study seeks to develop and validation a machine learning based point of care decision support tool to
standardize the approach to MS DMT discontinuation. This study will develop the machine learning algorithm
in a large retrospective clinical cohort and externally validate the tool in the “Discontinuation of disease
modifying therapies in multiple sclerosis” (DISCOMS; NCT 03073603) randomized, controlled, single-blinded,
clinical trial dataset during the R21 phase. In the R33 phase the validated point of care tool will be
implemented through a pragmatic randomized clinical trial to assess the adoption and impact on clinical
outcomes over 24 months. The overarching goal of this proposal is to create a decision support tool that will
provide a standardized approach to DMT discontinuation resulting in a reduction in risk exposure and financial
burden to people with MS.

Public health relevance
Project narrative Disease modifying treatments for multiple sclerosis (MS) have many known serious risks, and healthcare expenditures related to MS DMTs account for 40% of the $85 billion total annual cost of MS care in the United States. While there is biological evidence and clinical data supporting the discontinuation of DMT for certain patients, there are no biological markers or clinical support tools to aide with the complex decision to stop MS DMTs. We propose the development, validation, and implementation of a point of care decision support tool utilizing machine learning to address this significant unmet need in the field of MS care.